ST1 IMMUNOTOXIN TREATMENT FOR PREVENTION OF GVHD

This is a phase I/II trial of the use of monoclonal F(AB)2 fragment conjugated to the A chain of ricin. The monoclonal antibody recognizes the CD5 cell surface protein. T cells that are CD+5 internalize the immunotoxin and are killed, thus reducing the number of infused T cells and reducing the risk of GVHD> The therapy for rate of engraftment and rate of development of graft versus host disease is being assessed.